Imaging Acidosis and Immune Therapy in PDAC

Abstract
Pancreatic Ductal Adenocarcinoma (PDAC) is the most lethal of all cancers and is largely resistant to all
therapies, including immune therapies (IT). Despite this resistance, there are no fewer than 12 open clinical
trials investigating treatment of PDAC with checkpoint blockade IT. There are multiple mechanisms that can
account for this resistance, including the acidosis of PDAC tumors, which is due to high rates of glycolysis in
combination with poor perfusion. Placement of activated T cells in acidic conditions profoundly inhibits their
effector functions. We have shown that neutralization of tumor acidosis with oral NaHCO3 in murine models of
PDAC can lead to dramatic improvements in response to checkpoint blockade. However, phase I/IIa clinical
trials with bicarbonate failed to dose escalate. Thus, there is a compelling need to develop clinically viable
alternatives to achieve the same result, viz. neutralization of tumor acidity in vivo in order to combine with IT. A
therapy designed to directly neutralize tumor acidity is a clinically-tested CEACAM6-targeted urease (L-
DOS47, Helix Biopharma). This cleaves endogenous urea into two NH4+ and one CO2, thus alkalinizing local
pH, and this agent will be our primary focus in the proposed studies.
We will use these approaches to test the hypothesis that neutralizing tumor acidity with L-DOS47 will
be additive or synergistic with checkpoint blockade in mouse models of PDAC. Our preliminary data
support these hypotheses, yet there are gaps in our knowledge that need to be filled prior to embarking on
clinical trials combining L-DOS47 with immune therapy. Preliminary data have shown improved response to
checkpoint blockade in combination with L-DOS47 in Panc02 tumors; an immune competent model of PDAC,
and we plan to expand this to more biomedically relevant models in the current work. These will be addressed
in 3 Aims: Aim 1 will determine the in situ pharmacodynamics (PD) of these agents using molecular imaging of
1.1) pH and 1.2) enzyme activity in order to optimize dosing schema to achieve acid neutralization. In Aim 2,
we will combine these agents with checkpoint blockade (anti-PD1 and anti-PD-L1) to improve tumor control in
mouse models of PDAC engineered to express CEACAM6 (Panc02, UN-KPC960/961). A secondary endpoint
in this aim will be to develop imaging biomarkers of response that can be used prior to therapy to predict, and
during therapy to monitor, response. Aim 3 will address the fundamental question of HOW an acidic pH
induces T cell stasis. Preliminary data have shown that acidification of pHe induces a subtle, yet significant,
drop in pHi, which may be responsible for subsequent T-cell stasis. We will also investigate whether there is a
disruption of Ca2+ signaling dynamics, leading to altered NFAT distribution, and whether there is a differential
sensitivity of T-cells to acidosis, compared with acid-adapted or acid-naïve cancer cells and fibroblasts.
At the completion of this study, we will have developed a clinically translatable approach to improve IT in
PDAC as well as an improved understanding of the mechanism underlying acid inhibition.

Public health relevance
Narrative Immune therapy has shown great promise in the control of many cancers. However, it has been ineffective in Pancreatic Cancer and we hypothesize that this is due, in part, to the extremely acidic milieu that is present in pancreatic cancer. We have shown that neutralization of acidity in mouse models of pancreatic cancers can improve immune therapy and, in this proposal, we will develop methods that can be clinically translated with the expectation that this information will lead to clinical trials to improve immune therapy in pancreatic cancer patients.